SAGE Mental Health

A recent study of orphaned children in five low- and middle-income countries, including Kenya, showed that more
than 90% experience trauma by age 13; annual incidence of a traumatic event is 25%. The result is substantial
burden of post-traumatic stress and its long-term sequelae. Yet, the mental health services gap in African
countries is the highest in the world, and resources for children are particularly scarce. Scale-up of mental health
interventions through task-shifting models has great potential to narrow the mental health services gap. Lay
counselor delivery of evidence-based treatments can be implemented with fidelity and result in reduced post-
traumatic stress. Now, there is an urgent need for strategies that facilitate sustainability of scaled-up interventions
and, equally important, a need to equip leaders and policy makers with information about the generalizability of
the interventions to other communities. The goal of this K01 Mentored Research Scientist Career Development
award is to expand the candidate’s expertise to the science of dissemination and implementation. Through a
rigorous plan including coursework, directed reading, applied research experience, and individualized
mentorship from globally-recognized scientific experts, the candidate will acquire competencies in 4 areas:
(1) content expertise in dissemination and implementation of mental health evidence-based treatments,
(2)
mixed methods tools for conducting sustainment research
to identify strategies enabling the continuation of
scaled-up interventions, (3) approaches to generalize trial results and extend the policy reach of evidence-based
treatments, and (4) professional development to become an NIH-funded independent investigator conducting
culturally-sensitive research in low-resource settings.
The candidate has a team of interdisciplinary senior
scientists who are thought leaders in their respective fields, led by Primary Mentor Dr. Kathryn Whetten and co-
Mentors Dr. Shannon Dorsey and Dr. James Moody.
They are joined by three Scientific Advisors, Augustine
Wasonga, Dr. Kearsley Stewart, and Dr. Daniel Westreich. Their mentorship will guide a set of research aims
that expands an ongoing NIMH-funded implementation effectiveness trial in western Kenya. This research
specifically begins after all 40 sites in a cluster-randomized clinical trial are at least one year post-implementation.
Both qualitative methods and social network analysis will be used during the sustainment phase to identify the
critical strategies employed by lay counselors and the structural elements of their social networks that facilitate
continued sustainment. In addition, generalizability of the intervention effects in children will be estimated for all
This research is directly responsive to local interest in understanding the potential
for broader scale-up, addressing NIMH Strategic Objective 4 “Strengthening the Public Health Impact of NIH-
Supported Work,” specifically Objective 4.2 to “Strengthen research-practice partnerships to expedite…
sustained implementation...of evidence-based mental health service.” Results will identify testable strategies to
achieve continuation of mental health interventions implemented in low-resource settings.
orphaned children in Kenya.

Public health relevance
PROJECT NARRATIVE Trauma and post-traumatic stress disproportionately burden orphaned children in low-resource settings, and mental health services are often unavailable. While scale-up of interventions through lay counselor delivery of evidence-based treatments is promising, there is very limited knowledge on sustaining interventions after they are implemented or equipping leaders with information about potential effectiveness in other communities. This proposal, “Sustaining and Generalizing Evidence-based Mental Health interventions for children (SAGE-MH)” will innovatively expand an implementation effectiveness trial in western Kenya to examine strategies for continuation during sustainment and to assess generalizability to all orphaned children in Kenya.